Mechanisms of Candida auris Colonization in the Skin

Project Summary
Candida auris (CA), an emerging multi-drug resistant fungal pathogen that predominately colonizes in the skin
has recently been classified as an urgent threat by the US Centers for Disease Control and Prevention (CDC)
Antibiotic Threats Report. CA asymptomatically colonizes the skin for prolonged periods and rapidly spreads
between hospitalized patients and nursing home residents via nosocomial transmission resulting in outbreaks of
systemic infections. CA gains access to the blood in patients requiring indwelling devices leading to invasive
infections resulting in mortality ranging from 40 to 60 percent among CA infected patients. Majority of CA isolates
exhibit resistance to all three classes of FDA-approved antifungal drugs including azoles, polyenes, and
echinocandins posing a significant challenge to treat this fungal pathogen. Therefore, understanding the factors
regulating CA skin colonization is important to control CA outbreaks and prevent invasive CA infections.
Recently, we have uncovered that skin microbiota regulate the CA skin colonization. Based on our compelling
data, we will define the microbiota and host mediated mechanism(s) that control CA skin colonization. In Aim 1,
we will define how skin microbiota directly inhibit CA growth and skin colonization and In Aim 2, we will define
the host-mediated mechanisms through which skin microbiota regulate CA skin colonization. Understanding the
microbiota and host factors in the regulation of CA is expected to lead to a more complete understanding of the
factors that control CA skin colonization, with the long-term aim of identifying new antifungal therapeutic
strategies.

Public health relevance
Project Narrative Candida auris, an emerging multi-drug resistant fungal pathogen causes life-threatening infections in humans. This study will define the underlying mechanism(s) by which microbiota regulate the skin colonization of C. auris. Results from this study will expand the knowledge about how microbiota and host factors regulate C. auris, with the long-term goal of developing novel therapeutic strategies to prevent and control invasive C. auris infections.